ASSESSMENT OF MITOCHONDRIAL PHENOTYPE IN PLURIPOTENT CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We started a project in 2008 where we are genetically manipulating human fibroblasts from old and young patients. We are making those fibroblasts to become pluripotent. Our groups are: (1) skin fibroblasts from old patients;(2) fibroblasts from young patients;(3) induced pluripotent old fibroblasts;(4) induced pluripotent young fibroblasts;and (5) embryonic stem cells. We want to know if the induced pluripotent old (iPS old) resemble the young fibroblasts or the old ones, and the same with the iPS young.